Effect of fetal exposure to maternal inflammation on offspring Paneth cell development and homeostasis

Chorioamnionitis complicates up to 70% of preterm births, and is characterized by acute inflammation of the
placental/fetal unit, exposing the fetus to significant inflammation. These infants have an increased risk of
short- and long-term morbidities involving multiple organ systems including the intestine. However,
mechanisms by which fetal exposure to maternal inflammation (FEMI) leads to adverse outcomes remain
unclear. Our preliminary and published data show that an interleukin-6 (IL-6)-dependent loss of Paneth cells
contributes to FEMI-associated susceptibility to bowel injury. Our data suggest that FEMI leads to: IL-6-
dependent Paneth cell loss; lingering elevation of serum baseline levels of inflammatory cytokines, including
IL-6; clinically relevant intestinal injury; and increased susceptibility to secondary intestinal injury. However,
specific mechanisms underlying these effects including the source of IL-6, the site of IL-6-induced pathogenic
action, specific signal pathways by which Paneth cells are impacted, and subsequent consequences of Paneth
cell perturbation remain incompletely understood. Addressing this gap in knowledge is critical for restoring IL-6
modulation, a potential interventional opportunity for preventing FEMI-induced pathology. The objective of this
proposal is to delineate key mechanisms by which FEMI decreases Paneth cells and increases susceptibility to
intestinal injury in the offspring. Our central hypothesis is that fetal exposure to IL-6 from maternal or placental
(or both) sources is a key mechanism by which FEMI alters signal transducers and activators of transcription-1
signaling in the offspring, leading to increased interferon lambda signal pathways, reduced Paneth cell density,
and increased injury susceptibility. The rationale for undertaking this project is to gain a mechanistic advance
in knowledge of how FEMI leads to neonatal morbidity and mortality. Such knowledge will be critical to develop
novel preventative strategies, to prevent complications and mortality of prematurity, and to directly improve the
quality of life of pre-term infants. Our hypothesis will be tested through two aims: 1) Identify the site(s) of
pathologic action of IL-6 and downstream signaling pathways activated following FEMI, and 2) Determine the
effects of FEMI on pathways critical to Paneth cell homeostasis. The proposed research is significant and
innovative as our proposed studies will directly address the gap in knowledge regarding increased neonatal
morbidity and mortality following FEMI and specifically the impact on Paneth cells using novel in vivo, in vitro,
and ex vivo approaches to investigate the role of FEMI-induced IL-6 on fetal outcomes. This knowledge will
lead to development of targeted therapies to improve intestinal health.

Public health relevance
The proposed research is relevant to public health because 10% of all infants worldwide are born prematurely, and these infants are especially susceptible to bacterial infection, inflammation and, ultimately, tissue injury that can lead to death. The proposed study opens a new line of investigation focused on the role of maternal inflammation in the high susceptibility of premature infants to intestinal injury. Thus, the proposed experiments are relevant to the NIH mission of developing fundamental knowledge that will help to protect and improve human health by deepening our understanding of the processes of human growth and development.